Characterizing and treating peripheral nervous system dysfunction in Sanfilippo Syndrome

Title: Characterizing and treating peripheral nervous system dysfunction in Sanfilippo Syndrome
Mucopolysaccharidosis Type IIIA (MPS IIIA), also known as Sanfilippo Syndrome Type A, is a rare autosomal
recessive disorder that affects one in every 70,000 children worldwide, and currently there are no approved
therapies. Patients with MPS IIIA are unable to catabolize a subtype of cellular polysaccharides, known as
heparan sulfate (HS), due to inherited mutations in the gene encoding for the lysosomal enzyme, N-
sulfoglucosamine sulfohydrolase (SGSH). Deficiency in this enzyme leads to intra-lysosomal storage and
accumulation of HS, which results in severe neuropathology, including regression of intellectual and motor
abilities, behavioral problems, hearing loss, and dementia. Children born with this disorder exhibit developmental
abnormalities, organ failure, and neurodegeneration, which often result in death within the first two decades of
life. To date, MPS IIIA neuropathologic and therapeutic studies have focused predominantly on changes in the
central nervous system, especially in the brain, but little is known about the disease pathology in the peripheral
nervous system (PNS). Intriguingly, both MPS IIIA patients and mouse models display symptoms of
degeneration of the sensory and autonomic nervous system, including retinopathy, bowel issues, and
cardiomyopathy. Yet, the molecular mechanisms triggering the underlying peripheral neuropathy are virtually
unknown. The main objectives of this proposal are to develop novel disease models for MPS IIIA and to identify
therapeutic agents to lower the accumulation of HS in MPS IIIA cells. In Aim 1 of this proposal, our team will
utilize patient-derived induced pluripotent stem cells (iPSCs) to generate peripheral neural stem cell models to
recapitulate PNS phenotypes and dysfunction found in MPS IIIA patients. iPSCs from MPS IIIA patients with an
intermediate and severe clinical phenotype, respectively, will be differentiated into neural crest cells, peripheral
sensory neurons, and sympathetic neurons and evaluated for disease pathology, cell morphology, and neural
electrophysiology. In Aim 2 of the project, we will repurpose FDA-approved drugs recently identified through drug
screens to reduce HS biosynthesis for substrate reduction therapy for MPS IIIA. Promising compounds will be
assessed for their impact on HS content and lysosomal storage in primary human fibroblasts from MPS IIIA
patients. Efficacy of active agents will then be assayed for reduction of lysosomal storage of glycosaminoglycans
in iPSC-derived PNS models generated in Aim 1. Overall, the innovative strategies proposed here will develop
novel cellular models to improve our knowledge about the molecular underpinnings of PNS dysfunction in MPS
IIIA and will promote the discovery of new therapies by addressing the underlying cause of the disorder,
lysosomal accumulation of heparan sulfate.

Public health relevance
PROJECT NARRATIVE Mucopolysaccharidosis Type IIIA, or Sanfilippo Syndrome A, is an inherited disorder where patients develop severe brain abnormalities and exhibit degeneration in the peripheral nervous system, and there are no approved therapies. The significance of this work lies in the development of new patient-derived neuronal cell models to improve our knowledge about the molecular underpinnings of dysfunction in the PNS in Sanfilippo Syndrome to help elucidate new therapeutic targets for the disease. Additionally, drug candidates identified in these studies will provide new and accessible treatments for this orphan disease as well as other disorders where heparan sulfate catabolism goes awry.